Bioactive immune-modulating nanodrug for sepsis treatment

Abstract
The overwhelming immune response to systemic infection and traumatic injury may result in
hyperinflammation, multiple organ failure, and death in sepsis. Sepsis is a complex and heterogeneous critical
illness with multiple dynamic dysregulated inflammatory pathways triggered by systemically released Damage
or Pathogen Associated Molecular Patterns (DAMPs/PAMPs). Dysregulated inflammation also contributes to
the pathogenesis of many other diseases, e.g. autoimmune diseases, chronic wounds, etc. Clinical
challenges: Versatile immune modulation therapy to resolve inflammation in critical illness is still a significant
unmet need. Therapeutics targeting a specific inflammatory mediator, e.g. cytokines or DAMPs/PAMPs, have
failed to improve sepsis survival in the clinic. On the contrary, anti-inflammatory steroid drugs are associated
with immune suppression, resulting in an increased risk of secondary infections. Solutions: I have developed
a novel, well-defined linear-dendritic telodendrimer (TD) nanoplatform for structure-based nanocarrier design in
therapeutic delivery and immune modulation. In my on-going R01 project, I have developed TD nanotrap (NT)
platforms for both systemic injection and hemoperfusion therapy to passively capture a broad spectrum of the
overflowing inflammatory signals simultaneously, e.g. LPS, cytokines, and DAMPs/PAMPs, to restore immune
regulation. The optimized TD NT resins provide a cure in a severe sepsis mouse model when combined with a
moderate dose of antibiotics, as reported in our recent publications in Nature Communications 2020 and
Advanced Therapeutics 2022. Recently, we created a series of novel TD constructs with a well-defined and
optimal combination of negative charges and hydrophobic moieties that can actively block immune cell
inflammation triggered by various immune stimulating molecules, e.g. endotoxins from gram negative bacteria
(LPS) and gram positive bacteria (LTA), as well as bacterial cell lysate and even TNF-α. At the same time,
these TDs can assemble into nanocarriers for the encapsulation of vital antibiotics for infection control; they
can also effectively deliver endogenous potent pyroptosis inhibitors to control hyperinflammation and prevent
immune suppression in the later stage of sepsis. In the next five years, I will focus on the development of
transformative, next generation multimodal TD nanodrugs for sepsis treatment in three directions: PROJECT-
1: Develop a novel next-generation bioactive TD nanodrug for inflammation control; PROJECT-2: Develop
multi-functional TD nanotherapeutics to inhibit pyroptosis in sepsis; PROJECT-3: Develop multimodal TD
nanomedicine to control infection and inflammation in sepsis. In addition to sepsis, these TD nanodrugs can
also be applied in other inflammatory diseases, e.g., ARDS, chronic wounds, cancer perioperative
inflammation, rheumatoid arthritis, and inflammatory bowel diseases, etc. In summary, our innovative TD
nanodrugs are poised to provide resolution to inflammation and improve sepsis survival in the clinic by both
immune modulation and infection control.

Public health relevance
Bioactive immune-modulating nanodrug for sepsis treatment Project Narrative Sepsis, commonly caused by severe trauma and infection, results in dysregulated inflammation leading to tissue damage/organ failure, which unfortunately lacks effective pharmacological interventions in the clinic to improve patient survival. In recent years, my lab has developed a novel unique telodendrimer nanoplatform for both therapeutic delivery and versatile active immune modulation. In the next five years, my research program will focus on the development of the next generation of TD nanodrug for (1) active fine-tuned inflammation control against a broad spectrum of immune stimuli via pleiotropic mechanisms; (2) control of both hyperinflammation and immune suppression in sepsis by blocking cytokine storm and pyroptosis; and (3) delivery of vital antibiotics for simultaneous control of MDR infection and inflammation in sepsis.